Microphysiological Model of Human Cardiac Sympathetic Innervation

PROJECT SUMMARY
An inherited heart condition known as arrhythmogenic cardiomyopathy (ACM) is characterized by abnormal
mechanical coupling of cardiomyocytes, increasing fibrosis, fat deposition, and severe arrhythmias that can lead
to rapid cardiac death. Denervation of the cardiac sympathetic nerves is still a treatment option for ACM, which
suggests that the functional modification of cardiac sympathetic neurons may be detrimental in the setting of this
disease. However, there is a lack of understanding about both the development of sympathetic maladaptation
and its unique contribution to ACM disease. To address this, this supplemental project focuses on determining
how and when remodeling of cardiac sympathetic neurons happens, as well as how they contribute to the
etiology of the disease. To do this, we will use genetically manipulated ACM animal models and investigate the
role of postganglionic sympathetic neurons in ACM development. The Specific Aims of this supplemental project
are (1) to identify key transcriptional programs and how they interact spatiotemporally to drive pathologic
remodeling of postganglionic cardiac sympathetic neurons in ACM pathogenesis and (2) to define the functional
role of pathogenic remodeling of postganglionic cardiac sympathetic neurons in ACM pathology. This information
is expected to shed light on how interplay between altered neurons and cardiomyocytes contributes to the
pathophysiology of ACM.

Public health relevance
PROJECT NARRATIVE We will investigate how and when sympathetic cardiac neurons change, as well as how they contribute to the etiology of arrhythmogenic cardiomyopathy, using animal models. These findings are expected to shed light on how the interplay between altered neurons and cardiomyocytes contributes to the pathophysiology of the disease and may have implications for early interventional therapies.